CK25-035 Monitoring, Operations Research, Evaluation of Tools for Malaria Control and Prevention in Kenya

Project Summary: This CoAg between CDC's Malaria Branch and Liverpool School of Tropical Medicine
(LSTM) builds on a 15-year collaboration with the Kenya Medical Research Institute (KEMRI) in western
Kenya. The research strategy addresses 3 objectives through 13 interconnected activities. Under the first
objective, to inform malaria control in Kenya, we will evaluate novel preventive interventions including
assessment of monoclonal antibodies in 6-week-old infants (Activity [Act]-1); expanded use of R21 malaria
vaccine beyond routine childhood immunization for post-discharge prevention in hospitalised children with
severe anaemia and in pregnancy (Act-2); evaluation of M5717+pyronaridine as a novel prevention
strategy for malaria in pregnancy (Act-3); and testing of spatial repellents and next-generation insecticide-
treated nets (Act-4). To improve intervention uptake, we will support implementation of post-discharge
malaria chemoprevention following WHO's 2022 recommendation (Act-5), strengthen community-based
antenatal care delivery through innovative digital platforms (Act-6), and develop implementation strategies
for intermittent preventive treatment in schoolchildren (Act-7). Case management activities include
evaluating the malaria case management pathway (Act-8), monitoring antimalarial drug efficacy (Act-9),
and developing novel methods to assess chemoprevention efficacy (Act-10). For the second objective,
advancing epidemiologic methods for monitoring impact, we will create an enhanced epidemiological
surveillance network integrating facility and community-based data (Act-11) and expanding entomological
monitoring focused on insecticide resistance and emerging vectors like Anopheles stephensi (Act-12). The
third objective focuses on advancing laboratory methods and strengthening local capacity. We will
establish advanced molecular methods, including next-generation sequencing, implement serological
testing using multiplex bead-based assays, develop quality management systems for routine microscopy,
and enhance capacity for detecting drug resistance markers and monitoring vaccine escape mutants (all
under Act-13). This research leverages KEMRI's extensive infrastructure including state-of-the-art
laboratories, demographic surveillance systems covering 260,000 participants, GCP-compliant pharmacies
and clinical research centers at major hospitals in western Kenya. The collaboration combines LSTM's
global malaria expertise, CDC's technical capabilities, and KEMRI's regional research infrastructure. The
strong partnership with Kenya's National Malaria Control Program and County Health Management Teams
ensure research findings translate directly to policy. The program includes extensive capacity building
through PhD training, postdoctoral fellowships, and establishment of sustainable laboratory capabilities.
This strategy addresses critical challenges in malaria control while building local research capacity to
generate evidence that will inform national and global malaria policy.

Public health relevance
Project Narrative This cooperative agreement supports a collaboration between the Kenya Medical Research Institute (KEMRI), US CDC, and Liverpool School of Tropical Medicine (LSTM) to help the Kenyan Ministry of Health address key challenges in malaria control through a comprehensive research program spanning novel preventive interventions (including monoclonal antibodies, next-generation vaccines, and vector control), improved surveillance systems, and strengthened laboratory capacity. Through 13 interconnected research activities, this partnership will evaluate novel tools to combat emerging threats like drug and insecticide resistance while strengthening Kenya's capacity to monitor and respond to changes in malaria transmission through enhanced epidemiological and entomological surveillance networks integrated with upgraded molecular laboratory capabilities. The research findings will directly inform national and global malaria control policies whilst building sustainable local research capacity through training Kenyan scientists, ultimately aiming to reduce malaria morbidity and mortality in Kenya and similar high- transmission settings across sub-Saharan Africa.